Influence of the locus coeruleus on fear learning and threat processing in the ventral hippocampus

Abstract
The locus coeruleus (LC) and ventral hippocampus (vHPC) both influence our response to threatening stimuli.
Research to date has focused primarily on the contribution each of these structures makes to fear learning and
anxiety. However, few studies have examined the interactions that occur between the LC and vHPC during
threat processing. The LC is typically thought to provide a salience signal to the HPC and other brain regions,
that enhances plasticity and facilitates memory formation. However, the LC and vHPC have also been shown
to drive innate anxiety-related behaviors in stressful situations. To resolve this apparent discrepancy, we will
test the novel idea that fear learning and innate anxiety are both controlled by distinct oscillations in the LC
(phasic vs tonic firing) that are transmitted to the vHPC when a threat is encountered. Acute, fear-inducing
stimuli have been shown to produce large, transient responses in the LC and the vHPC. For example, aversive
footshock produces phasic activity in both structures that can persist for up to several seconds after the
stimulus has terminated. As phasic LC responses are typically associated with focused attention and the
encoding of salient stimuli, we hypothesize that phasic activity in the LC promotes fear learning by enhancing
shock processing in the vHPC. In contrast, situations that induce anxiety, such as open, unsheltered
environments, produce smaller, but longer lasting increases in tonic activity in the LC. Consequently, we
hypothesize that the LC elicits anxiety-related behaviors when a potential threat is encountered by inducing
tonic firing in the vHPC. To test these ideas, we will use a multidisciplinary approach that combines in vivo fiber
photometry with cell-type specific optogenetics to simultaneously monitor vHPC activity while manipulating LC
neurons during fear conditioning and situations that provoke anxiety. Follow-up studies will build on these
results by using in vivo calcium imaging to determine the effects of tonic and phasic LC firing on the activity of
shock-responsive and anxiety-responsive cells in the vHPC.

Public health relevance
Project Narrative Disorders related to fear learning and threat processing represent the most common form of mental illness in the United States, with more than 30% of Americans experiencing some form of anxiety disorder at some point in their lifetime. Consequently, a major goal of the NIH is to understand the neural mechanisms underlying both adaptive and maladaptive fear and anxiety. The LC and vHPC are known to be involved in multiple forms of threat processing, but it is not known if interactions between these structures produce distinct physiological states that control fear and anxiety-related behaviors. This represents a major gap in our understanding of the neural systems that process and respond to threats. In addition, altered catecholamine release in the hippocampus accompanies many human disorders including schizophrenia, bipolar disorder, and ADHD, which are regularly comorbid with anxiety disorders. To determine how altered catecholamine levels impact these disorders, it is essential to establish the basic cognitive and behavioral functions of neuromodulatory inputs to the hippocampus.